New Catalytic Methods for the Synthesis of Complex Molecules

Project Summary
The development of novel therapeutics is driven in large part by the unique chemical space that
can be easily accessed by established and road-tested synthetic methods. Advancements in
chemical synthesis and catalysis open fresh structural space in the search for new medicinal
agents. This MIRA seeks to continue our long-term efforts to develop innovative transformations
and synthetic tactics to provide biomedical researchers with new tools for rapid structure activity
relationship (SAR) studies and access to novel chemical structures using organic photoredox
catalysis. We anticipate these methods will help to streamline the drug development process.
Four main research themes will be the focus of this grant – 1) site-selective and functional
group-directed C-H functionalization; 2) New direct functional group bioisostere replacement
chemistry; 3) programmable synthesis of 4) the use of photochemical-driven methods as new
tactics for complex target-oriented synthesis.
The rationale for this research is that novel and simple chemical reactivity will aid in the design
of new pharmaceuticals. These new methods are innovative as they make use of light-driven
organic catalysts that enable previously unknown chemical reactivity. This research program is
significant as it will expedite the synthesis of novel complex organic fragments including known
pharmacophores and bioisosteres of interest to biomedical researchers in the pharmaceutical
discovery and development phase.

Public health relevance
Project Narrative The objective of this research program is to invent new catalytic synthetic protocols for high value transformations of simple hydrocarbon-containing compounds typically found in most pharmaceuticals. We will use simple light-harvesting organic dyes that act as powerful single electron oxidants to effect single electron transfer reactions to generate highly reactive radical species that will be allow for the rapid derivatization of medicinal agents.